Area 3b hand cortex in primate: the targets and sources of extra-hand suppressive surrounds

Summary
Our previous studies have revealed a complex organization of receptive fields (RFs) of neurons in primary
somatosensory cortex of monkeys (area 3b). The neurons have small excitatory centers that create the
somatotopic map of the hand, a suppressive surround that includes all of the rest of the glabrous hand, and a
weaker suppressive surround that includes all of the skin on the other hand (the “extra hand” surround). We
propose to determine if neurons in different layers have similar or different surrounds, what surround features
are relayed from the thalamus to area 3b neurons, and the connections that mediate different parts of the
surround by inactivating cortical areas that directly or indirectly provide feedback to area 3b hand neurons. In
addition, we will determine how a major loss of sensory inputs from the hand, due to selective spinal cord
lesions, alters the center-surround relationships of neurons in the deprived and non-deprived 3b hand cortex,
even after extensive post lesion recovery of 3b reactivation and hand use. The expected results will greatly
expand our understanding of how tactile information from the hands is processed in the somatosensory
system, and how processing is impaired and recovered following sensory loss. These results will have a clear
impact on therapeutic intervention following spinal cord injury.

Public health relevance
Narrative The receptive fields neurons in primary somatosensory cortex of primates have excitatory centers, suppressive near surrounds on same hand, and far surrounds on the other hand. We will determine the neural sources of these features, and reveal how sensory loss alters these features, even after long-term recovery from spinal cord injury.